Neural circuits of frustration

Aggression—acting with the intent to inflict harm—is a universal component of social behavior, and all too often
the grim subject of the daily news. One of the most reliable triggers of aggression is frustration, or failing to
achieve an expected reward. This state can be adaptive, energizing behaviors to overcome barriers. But it can
also lead to anger and violence. In disorders as disparate as PTSD, bipolar disorder, and autism, low frustration
tolerance and uncontrolled aggression are among the most prevalent and impairing symptoms in psychiatry. Yet
the neurobiology of these behaviors is poorly understood, and current treatment options are grossly inadequate.
This proposal aims to define the role of two neuromodulators—dopamine (DA) and serotonin (5HT)—in the
neural response to frustrating events. In Aim 1, the candidate will create a mouse model of frustration by
combining conditioning tasks with the resident-intruder assay, in which an intruder mouse is added to a
resident’s cage to elicit aggression. On test days, the conditioning task will end with an unexpectedly negative
outcome, eliciting greater aggression from the resident mouse. In Aim 2, the candidate will use fiber photometry
and optogenetics to record and manipulate DA neuron activity and DA release in the nucleus accumbens (NAc)
while mice perform the frustration task. DA is a key modulator of motivated behaviors, and has long been
considered pro-aggressive. Few studies, however, have recorded DA during frustration or aggression. This
experiment will test whether DA release tonically increases with frustration, triggering aggression. In Aim 3, the
candidate will use fiber photometry and optogenetics to record and manipulate 5HT neuron activity and 5HT
release in the NAc during the frustration task. Unlike DA, 5HT is thought to inhibit behavior, including
aggression. But 5HT neurons have not been recorded during aggression. This Aim will test the hypothesis that
5HT release decreases with frustration, and that larger decreases facilitate greater aggression.
The proposed studies would be among the first to examine the neural circuit mechanisms of frustration. In the
process, the candidate will supplement his background in electrophysiology in head-fixed animals to become
proficient in social behaviors and calcium imaging. He will work with an advisory committee comprising world
leaders in human (Dr. Emil Coccaro) and rodent (Dr. Klaus Miczek) aggression, frustration (Dr. Ellen
Leibenluft), and 5HT (Dr. Liqun Luo), in addition to his primary mentor Dr. Rob Malenka and his career
development mentor Dr. Alan Schatzberg. He will take full advantage of the intellectually vibrant environment
at Stanford and supplement his technical training with high-quality didactic and professional training via
frequent mentor interactions, targeted coursework, and other career and intellectual growth opportunities. By
the end of the fellowship, the candidate will be positioned to launch a career as an independent investigator
leading a translational research program on the neural basis of aggression and irritability.

Public health relevance
Low frustration tolerance and uncontrolled aggression are common and impairing symptoms in psychiatric disorders as varied as PTSD, bipolar disorder, and autism. Little is known, however, about the neural basis of these behaviors. This proposal uses cutting-edge technologies to reveal the neural circuits underlying frustration and aggression, with the ultimate goal of developing more effective therapies for patients across multiple disorders.